Role of ER-to-actin tethering in cell migration

ABSTRACT
Cell migration is critical for processes such as tissue development and repair. A key aspect of mesenchymal cell
migration is the formation and turnover of cellular adhesions, multilayered protein complexes that link the actin
cytoskeleton to the extracellular matrix. Adhesions must be turned over to enable cell migration, and defects in
adhesion disassembly underlie developmental defects in some tissues and cancer cell movement in metastasis.
Local intracellular calcium signaling by the endoplasmic reticulum (ER) precedes adhesion disassembly, but the
signals that initiate calcium signaling, as well as the mechanisms for how the ER is spatiotemporally targeted to
focal adhesions destined to turn over, are not known. This proposal presents preliminary data revealing a novel
ER-to-actin tether, calmin/CLMN, that links the ER to the cytoskeleton to influence cellular adhesion dynamics
and cell migration. Mechanistically, CLMN has actin-binding domains and localizes to ER tubules; in addition,
CLMN localizes to a subpopulation of cellular adhesions. CLMN-depleted migrating cells exhibit a greater
number of cellular adhesions and migrate more slowly than controls. The driving hypothesis of this proposal
is that CLMN mediates tethering of the ER to actin and facilitates adhesion turnover by positioning the
ER near actin to spatially localize calcium influx, in turn enabling cell migration. The research proposed
in this fellowship will use molecular biology, biochemical, and advanced microscopy techniques to determine the
mechanisms for localization and actin targeting by CLMN. Furthermore, the proposed research will use live cell
imaging of CLMN, ER, adhesion markers, and intracellular calcium biosensors in migrating cells to determine a)
the sequence of events in recruiting ER to adhesions to facilitate migration and b) how this sequence is perturbed
in the absence of CLMN. This work will fill a critical knowledge gap of how the ER interacts with the actin
cytoskeleton and spatially coordinates ER-actin crosstalk for cell migration. Taken together, this research
will also further our understanding of the mechanisms of adhesion disassembly during cell migration and inform
changes that occur during normal and diseased tissue development. The proposed research and training plan
will also prepare the applicant for a productive scientific career as an independent investigator leading studies
of how organelle-cytoskeleton interactions influence cell physiology.

Public health relevance
PROJECT NARRATIVE Properly coordinated cell movement, or migration, is required for healthy tissue development; however, we lack a complete understanding of how molecular players in adhesion are regulated to coordinate migration. Here, I identify a novel tether linking the endoplasmic reticulum (ER) to actin, CLMN, and present evidence that it is required for proper cell migration; I propose that CLMN-mediated ER-actin tethering regulates local targeting of calcium signaling at cell adhesions between the actin cytoskeleton and extracellular matrix, ultimately governing cell migration. By understanding how ER-actin interactions impact migration, we will inform mechanisms of tissue development regulation that are upended in developmental disorders, immune-signaling, and during cancer cell metastasis.